A Novel Multicomponent DMSO Free Cryococktail and Recovery Reagent for the Improved Cryopreservation of NK Cells

Abstract
The ultimate goal of cryopreservation (CP) is to develop a biobanking process that results in a post-thaw
level of cell viability and function similar to a sister population that has not undergone CP. Most methods
used for the clinical level CP of human Natural Killer (NK) cells and other cell therapy cells result in poor
recovery due to post-thaw necrosis and apoptosis yielding an inferior cell product which is infused into
patients. Our research team has shown through dozens of publications that human stem and somatic
cells undergo delayed onset cell death triggered primarily by apoptosis that occurs over a several day
period post thaw. These publications support the following questions critical to the clinical use of CP
solutions: (1) How much of the observed in vivo cell loss associated with post-thaw infusion of
cryopreserved cells is a result of the manifestation of delayed onset cell death that is attributable to the
CP solution and post-thaw protocol used in the clinic? (2) What triggers the apoptotic cascade that
results in delayed onset cell death? One hypothesis to be tested in this Phase I proposal is that this
delayed onset cell death may be a result of CP-triggered premature cell aging and senescence – a
hypothesis that is supported by our group’s publications showing that resveratrol, an activator of the
Sirtuin (longevity) genes, can improve post hypothermic preservation outcome by up to 10 fold in human
hepatocytes and mesenchymal stem cells. But this agent could also be acting through other molecular
means as well. Given, however, a July, 2023, publication reporting that select chemical cocktails have
been formulated that can reverse the cell aging process this hypothesis can now be tested using CP
solutions and post-thaw revival formulations that contain these non-proprietary age-reversing chemicals.
Since, over half or more of all cell therapy products in clinical trials today, including NK cells, are
cryopreserved in 10% DMSO which is highly toxic, many studies have investigated ways to improve CP
as well as to use alternative cryoprotective agents (CPAs) such as sugar alcohols to avoid the known
toxicity of DMSO. Indeed, a symposium at Cryo2023 was solely dedicated to discussing alternatives to
DMSO as CPAs making this focus a high priority in the CP sciences. Yet, to date no new CP process that
eliminates DMSO has been developed commercially. To achieve this milestone, first, DMSO must be
replaced with CPAs that can prevent the formation and re-crystallization of lethal ice during the CP
process. Second, a post-thaw recovery conditioning dilution/infusion reagent must be developed that can
prevent post-thaw delayed onset cell death and improve NK cell viability and function immediately
following thawing. Specific Aims of this project are the following: SA1) Develop Chillout - a non-toxic
CPA cryococktail to replace DMSO; SA2) Formulate RevitalICE – a first in class CP dilution reagent
designed to ameliorate post-thaw apoptosis/necrosis increasing NK survival and infusion efficacy and
SA3) Evaluate NK cell cytotoxic function following CP. Hypotheses to be tested in this Phase I project are
the following: (1) The apoptosis-dependent delayed onset cell death is initially triggered by CP-induced
premature cell aging leading to poor CP outcome; (2) NK CP cell survival and function can be improved
through the addition of cell stress modulators and age-reversing chemical cocktails; and (3) elimination of
DMSO will further reduce NK stress associated with CP. Hypotheses to be tested in the Phase II project
are the following: (1) A DMSO free CP solution can be developed with cell stress and age-reversing
modulators that is FDA and clinically acceptable for therapeutic application and results in better post CP
outcome than traditional solutions containing 10% DMSO: (2) Delayed onset cell death occurs in vivo in
animal models if NK cells are stored in DMSO-containing CP solutions but does not occur if the proposed
Chillout and RevitalICE containing cell stress and age-reversing modulators are used as the CP
formulations and post-thaw revival solutions. These efforts will result in improved NK and other cell
therapy cell CP and thereby improve clinical outcome for patients receiving these cells.

Public health relevance
Currently many clinical trials use frozen NK cells for cell therapy to treat a variety of cancers. Unfortunately, however, the cryopreservation process results in a substantial loss of cell viability and function due to the activation of complex molecular based cell stress response to the freeze/thaw process. Further, today the far majority, if not all, cryopreservation processes rely on DMSO (a toxic and mutagenetic agent) as the primary cryoprotective agent. This Phase I project is designed to develop a unique cryoprotective agent cocktail for NK cells that doesn’t contain toxic compounds such as DMSO. Additionally, we will develop a unique post-thaw cell stress molecular modulation reagent designed to increase recovery of NK cells post-thaw regardless of the cryopreservation media utilized. A unique hypothesis to be tested is whether the delayed onset cell death that occurs following thawing is due (in part or whole) to accelerated stress-based cell aging triggered by the cryopreservation process. Together these technologies will yield enhanced NK cell survival thereby improving NK cell therapy outcome for patients worldwide.